Elucidating Shared Risk of Brain Arteriolosclerosis and Related Pathologies with Multiple 'omics Modalities

Abstract
Brain arteriolosclerosis (B-ASC) is a cerebrovascular disease characterized by pathological thickening of
the arterioles in the brain. Non-Alzheimer’s disease brain pathologies, including B-ASC, are increasingly
recognized as important contributors to cognitive decline in aged individuals. In autopsy cohorts, B-ASC is
found in over 50% of participants aged eighty years or older at death. B-ASC is associated with multiple other
neuropathologies, including hippocampal sclerosis. Despite its clinical importance, the pathophysiology of brain
arteriolosclerosis and its mechanistic relationship to other pathologies are not well understood. We have
aggregated and harmonized genotype and autopsy data between four high-quality neuropathology cohorts: the
National Alzheimer’s Coordinating Center (NACC), the Religious Orders Study and the Memory and Aging
Project (ROSMAP), the Adult Changes in Thought Study (ACT), and the Alzheimer’s Disease Neuroimaging
Initiative Neuropathology Cohort (ADNI). In preliminary genetic association and functional genomic studies
using NACC participants, we identified multiple B-ASC risk loci that replicated in at least one independent
cohort and established a framework for genetic studies of neuropathological endophenotypes (NPE). In Aim 1,
we hypothesize that analyses employing gene expression and DNA methylation will further characterize
genomic risk factors for B-ASC pathology. We will investigate the relationship between B-ASC, gene
expression, and DNA methylation in the dorsolateral prefrontal cortex using ROSMAP. These analyses will be
followed by computational approaches that will estimate the contribution of different cell types and predict gene
expression from genotype data in other cohorts. In Aim 2, we hypothesize that B-ASC shares genomic risk with
associated NPE. We will first use our established analytic pipeline to perform genetic association studies of
NPE comorbid with B-ASC. We will then use statistical methods to quantify and localize shared genetic risk
between B-ASC and other NPE. Findings from these studies will provide a rigorous characterization of B-ASC
risk factors and relevant biological pathways. Our cross-trait analyses will help clarify B-ASC’s place in the
complex web of mixed brain pathologies common in aged individuals. The mentors and collaborators I have
recruited comprise an experienced and multidisciplinary team that includes two biostatisticians, a genetic
epidemiologist, and an experimental neuropathologist. This NIH F30 fellowship will provide the requisite
experience, knowledge, and skills necessary as preparation to the next stage in my career as a clinical
researcher.

Public health relevance
Project Narrative Brain arteriolosclerosis (B-ASC), the pathologic thickening of small blood vessels in the brain, is a common contributor of cognitive decline in aged individuals, but the genetic risk factors are poorly understood. This project will identify multi-omic risk factors of B-ASC and identify the shared genetic risk between B-ASC and associated neuropathologies. Findings will provide mechanistic insight into B-ASC and identify potential therapeutic targets.